The Tobacco Use Supplement to the Current Population Survey (TUS-CPS) Mortality Study DB

The Tobacco Use Supplement to the Current Population Survey (TUS-CPS) is an NCI-sponsored survey of tobacco use that has been administered as part of the US Census Bureau's Current Population Survey approximately every 3-4 years since 1992-93. This IAA establishes an agreement between the National Cancer Institute (NCI) and the U.S. Census Bureau (Census). The Census Bureau will provide technical and statistical support as the steward of the National Longitudinal Mortality Study (NLMS) - Tobacco Use Supplement to the Current Population Survey (TUS-CPS) linkage study data. The development of this database is meant to enable research by the National Cancer Institute (NCI) and its grantees. During FY2020, Census will specifically: a. Conduct a complete review of the CPS variables for relevancy to issues for research on tobacco-use. Develop appropriate categorizations of variables to permit analyses on non-sparse data. b. Develop a presentation to appeal for funding from other government agencies that may consider whether or not to be a sponsor of the Tobacco-Use Study. c. Obtain all CPS Tobacco-Use supplement files for the years 1995 to 2018 from the archives and prepare them for incorporation into one study. d. Create the Inter Agency Agreements necessary to obtain funding from interested sponsors identified through the presentations possible sponsoring candidates. e. Support statistical staff in conducting analytical research on TUS-CPS and TLMS databases for research that is identified in FY 2020. NCI has determined that it has a bona fide need for this activity to begin in FY2020 and realizes that it will not receive a benefit from this work until the items a. through e. listed above have been completed and the paperwork required for the match of the Tobacco-use Study to the NDI is completed by September 30, 2021.